STIM-Dependent Signaling in Cardiac Pathophysiology

DESCRIPTION (provided by applicant): The purpose of this K99/R00 grant is to assist Dr. Mancarella in transitioning to a stable independent research position in a research University where he can conduct his research in the cardiovascular field. Drs. Donald Gill and Steven Houser, two renowned experts in cell signaling and cardiovascular science, will assist Dr. Mancarella during this transition. During his postdoctoral training the candidate has investigated the biophysical properties of the Ca2+ sensors STIM1. These results suggest that STIM forms specialized proteins network able to capture Ca2+ signals from the near-membrane compartment and convert it in signals that activate gene transcription which take place distal from the signal source. The candidate theorized that STIM1 and STIM2-are required for calcium-concentration microdomains which communicate with the NFAT system to regulate the pathological growth of the myocardium. The candidate will combine data from imaging analysis, ion channels, bioinformatics, protein analysis and animal models to build a protein network to describe how inter-relations between proteins lead to cardiac hypertrophy and heart failure. During the K99 phase, the candidate will characterize the STIM-dependent Ca2+ signature in neonatal cardiomyocytes (Aim I) and isolate the ionic currents activated by STIM. To this end Dr. Mancarella will implement a combination of techniques such as, genetics, live-cell imaging, and electrophysiology to examine the functional role of STIM1 and STIM2 in the heart. Subsequently, (Aim 2) he will identify and characterize the protein compositions of the STIM-microdomains Interactome that govern pathological growth of the heart. Proteomic analysis and bioinformatics integration will allow a systematic assessment of the near-membrane STIM microdomains composition and function in the heart. To achieve his Goals Dr. Mancarella will be trained at Temple University Proteomic Center. During the R00 phase, Dr. Mancarella will test the hypothesis that STIM 1 and STIM2 are required for pathological growth of the heart. The experimental approach to this aim is based on obtain a cardiac specific STIM1/2 inducible double KO mouse model; this will be achieved by Cre/Lox technology. The resultant strain will allow a temporally and spatially controlled ablation of the STIM proteins in the heart. This model will serve as an in vivo model to validate the findings in aim1 and aim2 and expand towards: (a) Examine the role of STIM in adult cardiac functions (b) To investigate the role of STIM during pressure overload induced by thoracic aortic constriction (TAC) and examine, cardiac remodeling and cardiac functions. The evaluation will be extended to the isolated myocytes, including appearance, functions and Ca2+ dynamic at local as well as global level with the use of confocal microscopy. The multidisciplinary approach (biochemical and physiological) proposed will ensure a high quality training of the candidate.

Public health relevance
PUBLIC HEALTH RELEVANCE: Intracellular calcium regulates a variety of cell functions during cardiac hypertrophy and heart failure. We will use genetic mouse models to study how calcium sensors STIM proteins, regulate the activity of calcium ion channels and intracellular calcium levels in healthy and hypertrophic myocardium. These studies may facilitate the development of new pharmacological approaches for the treatment of cardiac hypertrophy and heart failure, the leading cause of death in the United States. __SpecificAimsTextDelimiter__ A. Specific Aims. Abnormal intracellular Ca2+ plays a crucial role in the development of hypertrophic heart disease, a leading health problem in the Western World. The goal of this proposal is to understand how Stromal Interaction proteins (STIM1- and STIM2-) mediated Ca2+ entry regulates pathological cardiac hypertrophy (CH). STIM proteins are sarcoplasmic (SR) Ca2+ sensors, which upon Ca2+ store discharge migrate into specialized microdomains near the plasma membrane to activate the Store Operated Ca2+ Channels (SOCC). I hypothesize that STIM- proteins are required for calcium-concentration microdomains which communicate with the calcineurin-NFAT system to regulate the pathological growth of the myocardium. The experimental design is centered on testing that STIM's microdomain contains various Ca2+ sensitive proteins clustered in proximity of the Ca2+ source and functioning as signal "transducers" of the store-operated Ca2+ entry. Thus, Ca2+ entering through SOCC is a "chemical switcher" for all Ca2+ sensitive proteins that are located into or in proximity of the STIM microdomains. Here, we will characterize the STIM-dependent Ca2+ entry signals, identify proteins responsible for the execution of STIM-dependent physiological processes in cardiomyocytes. The results obtained will be tested on a cardiac specific STIM1/STIM2 KO mouse model to examine the role of STIM, and its partners, in cardiac pathophysiology. This work is organized in 3 specific aims: Aim1. To examine the functional role of STIM1 and STIM2 in neonatal cardiomyocytes. To test the hypothesis that STIM is required for Ca2+-entry that ultimately drive cardiomyocyte growth, I will characterize the STIM-dependent "Ca2+ signature" in neonatal cardiomyocytes. In addition, I will isolate the ionic currents that show STIM-dependent function. To this end, I will use a combination of cultured neonatal mouse cardiomyocytes, genetics, live-cell imaging, and electrophysiology techniques. Due to the lack of pharmacological inhibitors for SOCC, I will use mouse neonatal cardiomyocytes isolated from STIM1 KO, STIM2 KO and STIM1/2 double KO mouse hearts. For each genotype, I will: (a) assess the amplitude of SOCC in STIM1-, STIM2- and STIM1/STIM2- KO; {(b) correlate STIM1 movements to near-membrane Ca2+ entry. For this task I will use the new genetically encoded calcium indicator GCAmP3; (c) I will isolate the store operated ion currents activated/inactivated by STIM, using a patch clamp approach }. {Aim2. Identification and characterization of the protein compositions "Interactome" of the STIM- microdomains that govern pathological growth of the heart. It is now established that Ca2+ microdomains provide a rapid route for activation of selected targets. This aims is based on the hypothesis that STIM- dependent Ca2+ entry acts as a 'Chemical Switch' of Ca2+ sensitive proteins positioned in the STIM-calcium- concentration microdomains. This placement of sensors within such microdomain promotes rapid and privileged Ca2+ signaling. In addition to the obvious targets such as protein kinases, calmodulin, and calcineurin, I will extend my analysis to identify the STIM-binding partners (interactome) responsible for mediating the cardiomyocytes specific response that leads to pathological cardiac hypertrophy. Proteomic and bioinformatics approaches will be undertaken to: (a) isolate and identify STIM-associated proteins by affinity isolation and GeLC-MS analysis; (b) validation and bioinformatics characterization of significantly altered proteins on the basis of pathway analyses ;} (c) measure of the Ca2+ dependent pathways end-points using NFAT- and MEF2-luciferase reporter. Aim3. Measuring the impact of STIM1/STIM2 gene loss in the pathological growth of the heart in-vivo. From the K99 phase I will have an understanding of the STIM-microdomain proteome composition and its architecture in cardiomyocytes. The new knowledge will be used in future investigations (R00 phase) to evaluate specific alterations in STIM-binding partners during in-vivo cardiac hypertrophy. The experimental approach will include: obtaining a cardiac specific STIM1/2 tamoxifen inducible double KO mouse. This will be achieved Cre-Lox strategy, in this model we will : (a) investigate the role of STIM in adult cardiac functions, which will be assessed by the use of echo, ECG and isolated heart (langendorff perfused heart); (b) examine the progression of CH in a pressure overload mouse model induced by transthoracic aorta constriction (TAC) and examine, cardiac function, tissue and electric remodeling; {(c) examine if deletion of STIM protein after TAC delay or even reverse cardiac hypertrophy development; d) investigation of the new, hypothetical, identified STIM binding partners.} During the K99 phase I will acquire new skills (proteomic, bioinformatics and pathways analysis) that will be crucial for my career as an independent investigator. The Awards will also facilitate the transition from a mentored postdoctoral position to a stable independent research position in a highly qualified academic environment, with my own independent founding. Moreover, the objective of my K99 phase will be to publish the composition of the STIM-microdomains in cardiomyocytes. Within the five years covered by this award (K99/R00 phases) I aim to identify new proteins that transduce the Ca2+ signaling that are not targeted by existing treatments, which is potentially valuable since new therapeutic agents will have to be added to the current treatments of cardiac hypertrophy.